Plasminogen activator inhibitor 1 (PAI1) as a therapeutic target for maternal endothelial dysfunction in preeclampsia

Summary
Preeclampsia is a hypertensive disorder of pregnancy that causes 70,000 maternal and 500,000 neonatal
deaths per year globally. The only specific treatment is delivery of the baby and placenta, resulting in 3-4 times
more frequent preterm birth compared to normotensive pregnancies. The underlying pathophysiology of
preeclampsia is likely heterogeneous, but the culmination is maternal endothelial dysfunction causing
hypertension, kidney failure, coagulopathy, and strokes. A history of preeclampsia is associated with ischemic
heart disease and renal failure for the mother and long-term cardiovascular disease in the offspring. Therapies
that specifically improve maternal endothelial function are urgently needed to permit safe pregnancy
prolongation and improve mother and child outcomes.
Plasminogen activator inhibitor 1 (PAI1) is elevated in preeclampsia, yet its pathophysiologic role is unknown.
PAI1 plays a deleterious role in numerous cardiovascular diseases, and pharmaceuticals are in development.
We and others have shown that PAI1 promotes endothelial dysfunction through inhibition of endothelial nitric
oxide synthase and promotion of inflammatory and vasoactive genes that are upregulated in preeclampsia.
PAI1’s role in hemostasis is important in pregnancy, but our preliminary findings suggest that PAI1-mediated
inflammation is independent of its role in the coagulation cascade. These data suggest PAI1 contributes to the
pathophysiology of preeclampsia and make it a promising therapeutic target.
The objective of this proposal is to gain insights into maternal endothelial dysfunction that can be leveraged to
develop novel therapeutic strategies with a specific focus on PAI1 as a drug target. In Aim 1, we test whether
PAI1’s inflammatory effect can be blocked without disrupting its role in hemostasis by identifying how PAI1
alters inflammatory signaling pathways and determining the molecular interactions required. In Aim 2, we test
the relevance of PAI1-mediated endothelial dysfunction in plasma from patients with preeclampsia using a
PAI1 inhibitor. We use statistical models to associate clinical and biochemical characteristics with the effect of
preeclamptic plasma on endothelial function. In Aim 3, we use a mouse model that recapitulates endothelial
dysfunction in preeclampsia to test the role of PAI1 in mediating systemic effects including blood pressure,
vascular function, cytokines, and renal damage. We test the in vivo efficacy of blocking PAI1 therapeutically.
There is no treatment for preeclampsia, which leads to long-term cardiovascular disease for mother and child.
This project mechanistically investigates the therapeutic potential of targeting PAI1 to improve endothelial
function while also collecting new hypothesis-generating data about the effect of plasma proteins in
preeclampsia on the endothelium. Our studies will drive future drug discovery to specifically target endothelial
function with the goal of prolonging pregnancy and improving the health of the mother and baby.

Public health relevance
Project Narrative Preeclampsia is a hypertensive disorder of pregnancy that causes 70,000 maternal and 500,000 neonatal deaths per year globally and leads to long-term cardiovascular disease for survivors. This proposal investigates the mechanisms by which plasminogen activator inhibitor 1 contributes to the development of preeclampsia. The ultimate objective of this work is to gain insights into maternal endothelial dysfunction that can be leveraged to develop new therapeutic strategies for preeclampsia.